Dissecting the Ketone Metabolic Axis in Heart Failure with Reduced Ejection Fraction

Despite significant advances in the treatment of patients with heart failure with reduced ejection fraction
(HFrEF), substantial residual morbidity and mortality continues to plague the contemporary treatment era. The
cardinal clinical feature of patients with HF is reduced exercise capacity, which is associated with substantially
reduced quality of life. Even with insights into diverse mechanisms of myocardial dysfunction, most current
medical treatment focuses on modulating the "neurohormonal axis", and orthogonal approaches are direly
needed. Recent preclinical and clinical data from our team and others demonstrate that exogenous delivery of
ketone therapy improves HF hemodynamics, suggesting potential ergogenic benefits. Our research has also
highlighted the contribution of skeletal muscle abnormalities to impaired exercise tolerance in HF, and limited
data suggest beneficial effects of ketones in reducing peripheral anaerobic carbohydrate metabolism in healthy
volunteers. We therefore seek to understand the potential benefits of therapeutic ketosis in patients with HFrEF
by performing deep phenotyping of myocardial, peripheral musculature, and metabolic contributions. Aim 1 will
determine the acute effects of exogenous ketone ester administration on functional capacity and investigate
potential myocardial and vascular mechanisms of benefit in a crossover, placebo-controlled trial. Aim 2 will
compare whether ketone ester therapy alters systemic carbohydrate metabolism through targeted
metabolomics, stable isotope infusions, and exercise measures of gas exchange. Aim 3 will investigate the
effects of ketone therapy on peripheral intramuscular lactate production and perfusion using state-of-the-art
magnetic resonance imaging protocols. Such studies will leverage the rich translational research environment
at the University of Pennsylvania, including the Center for Human Phenomic Sciences, a Clinical and
Translational Research Award (CTSA) initiative, and the Center for Magnetic Resonance and Optical Imaging.
If beneficial, our results would add to the burgeoning literature, demonstrating the importance of targeting the
"ketone metabolic axis" as a treatment strategy to help improve exercise capacity and quality of life, and would
inspire larger, randomized trials of ketone therapy. Dr. Selvaraj, an early career investigator and a fellow in
advanced heart failure, has a long-term goal of becoming an independently funded cardiovascular researcher
with a focus on cardiovascular metabolic interventions in HF and using deep phenotyping techniques to define
pathways of benefit. Thsese research aims are part of a comprehensive training plan and will be supervised by
a mentorship team spanning the basic science, translational, and clinic spectrum with rich experience in
cardiovascular metabolism in HF, metabolomic profiling, deep phenotyping during early stage studies of HF
therapeutics, and molecular metabolic imaging. This diverse and collaborative team will guide Dr. Selvaraj's
transition to an independently funded research career with extension of findings to low output HF syndromes.

Public health relevance
Patients who have heart failure, or the inability of the heart to pump blood efficiently to the body, have reduced quality of life, exercise intolerance, and are at greater risk for poor outcomes including death. This proposal seeks to define a novel pathway of treatment in patients with heart failure using an alternative energy source (ketone bodies). If beneficial, the results of our study may inspire larger studies and trials of such therapy in patients with heart failure in order to improve symptoms, quality of life, and ultimately reduce morbidity and mortality from heart failure.